End-of-life care quality for adolescents and young adults with cancer: Including the patient voice in quality assessment

ABSTRACT.
The proposed study is a first competitive renewal of a 5-year U01 award to examine end-of-life (EOL) care quality
for adolescents and young adults (AYAs) with cancer. AYAs with cancer are a growing population with unique
needs and vulnerabilities. At an age when the world should be opening to them, AYAs with advanced disease
face the profound losses inherent in a life cut short. Research into their EOL care experiences has been limited,
hindering development of care models and interventions to support AYAs facing untimely death.
In our first funding cycle, we engaged AYAs with advanced cancer, family caregivers, and clinicians to define
EOL care quality for AYAs. Measures developed for older adults center on aspects of care delivery like
hospitalizations and use of hospice. In contrast, AYAs’ priorities focused on the extent to which care met their
personal preferences, including support of relationships, information needs, and attainment of life goals. We
used results to develop a novel set of EOL care quality measures centered on the unique needs of AYAs,
including a survey to allow for patient reports across all 32 quality measures in 7 broad domains.
We now propose to build on this work to measure AYAs’ EOL care quality, as they themselves define it, with a
special focus on Black, Asian, and Hispanic AYAs. We will, first, measure the quality of care received by AYAs
living with advanced cancer using our newly developed patient-centered quality measures (Aim 1). We will
survey 500 AYAs from 4 sites who are living with relapsed or stage IV cancer, with surveys administered
prospectively every 3 months for 1 year or until death. Findings will be used to identify areas of deficiency in
quality, a needed step to inform targeted interventions. Second, we will examine care quality and barriers to high
quality care experienced by Black, Asian, and Hispanic AYAs (Aim 2). We will assess disparities in patient-
centered care quality from Aim 1 surveys by race and ethnicity, and perform in-depth interviews among Black,
Asian, Hispanic, and White AYAs to identify barriers to high quality care. Finally, we will develop a process to
implement patient-reported quality measures into clinical workflows, allowing patients to report on experiences
and conveying results in real time to clinical teams (Aim 3). We will work with AYAs, caregivers, and clinicians
to answer key questions about the optimal timing and frequency of assessment and best methods for reporting
results to clinical teams, to facilitate future wider scale implementation and ensure that quality measures can
inform care for AYAs living with advanced disease. Throughout the study, we will leverage the strengths of our
productive team, robust research sites, engaged stakeholders, and diverse patient population.
At the end of the award period, we will have assessed the quality of care for AYAs with advanced cancer as they
themselves define it, identified special barriers faced by historically marginalized populations, and developed a
process for implementation of patient-centered quality measures into clinical workflow. We will be prepared to
develop responsive interventions to improve care and mitigate disparities for AYAs with advanced disease.

Public health relevance
PROJECT NARRATIVE. Adolescents and young adults (AYAs) with cancer aged 12-39 account for nearly 90,000 new cancer diagnoses in the United States each year, and cancer is AYAs’ leading disease-related cause of death. This study will evaluate end-of-life care quality, as defined by AYAs themselves, using a novel set of patient-reported quality measures that capture AYAs’ values for care; identify disparities in quality for AYAs; and develop a process to allow patients to report on quality in real time, to improve care. This work will enable development of interventions to improve adolescent and young adult end-of-life care delivery.